MICROCHEMISTRY and PROTEOMICS

The Microchemistry and Proteomics Facility (MPF) supports laboratory and clinical research programs at MSKCC by (i) providing synthetic peptides and by (ii) performing mass spectrometric and amino acid sequence analyses of proteins and peptides, generally for the purpose of identification, relative quantitative analysis and post-translational modification (PTM) analysis. Synthetic molecules are made according to specifications provided by the investigator. Samples submitted for identification (either single proteins or mixtures), for PTM analysis or N-terminal sequencing are prepared by the lab requesting service. Information on chemistries and instrumentation, and expert advice on experimental approaches are provided by facility staff when needed. The goal of proteomics is to analyze changing levels, local concentrations and post-translational modifications of proteins in a cell, as well as to analyze higher-order networks of protein-protein interactions. Proteins and protein modifications are critical in the complex signaling pathways and regulatory processes underlying cell growth, division, differentiation, DNA repair, development, senescence, and in responses to bioactive agents, genetic alterations and disease. Dissection of multi-component protein complexes is therefore increasingly the focus of studies on molecular control mechanisms. Identification of unique components provides a powerful approach to the selective retrieval and identification of the companions. The impact that these services have provided, in facilitating research projects and enabling the timely progression of high priority research, can be recognized throughout the reports of the several research programs.